Add-on: Bridge Funding for Pelvic Floor Disorder Network (PFDN)

PROJECT SUMMARY (See instructions): RTI International proposes to continue to serve as the data coordinating center (DCC) for the NICHD Pelvic Floor Disorders Network (PFDN) in support of its mission to improve the care of women with pelvic floor disorders (PFDs) by conducting well-designed multicenter observational studies and clinical trials to inform diagnosis, prevention, and treatment. We will build on our work as the DCC in the current PFDN cycle to provide PFDN with statistical leadership, statistical data analysis and reporting, and operational support through data management and logistical services. Specifically, we will (1) continue monitoring ongoing Network protocols; (2) provide data management, including preparation of public data files; (3) prepare reports, including safety reports for the Data and Safety Monitoring Board; (4) collaborate in the analysis of data and publication of study results; (5) coordinate collection and transport of biological specimens; and (6) provide all other support, including management of capitation payments to clinical sites, and logistical coordination of meetings and communications necessary to run an efficient and productive Network.

Public health relevance
Project Narrative The Pelvic Floor Disorders Network (PFDN) was established in 2001 to improve the care of women with pelvic floor disorders by conducting well-designed multicenter observational studies and clinical trials to inform diagnosis, prevention, and treatment. A qualified, experienced data coordinating center is critical in helping the PFDN optimize research productivity through effective study design, implementation, data collection, quality assurance, monitoring, and statistical analysis. RTI International will continue to provide multidisciplinary expertise to support high-impact collaborative clinical research studies and provide communications and logistical support to optimize the efficiency and productivity of PFDN.